Targeting of E-cadherin-negative diffuse-type gastric cancer

PROJECT SUMMARY/ABSTRACT
Gastric cancer is the fourth most common cause of cancer deaths worldwide, with five-year survival rates of
slightly over 20%. More than 90% of gastric cancer cases belong to gastric adenocarcinoma (GAC), which can
be further divided into intestinal-type gastric cancer (IGC) and diffuse-type gastric adenocarcinoma (DGAC).
While the overall incidence of GC has decreased, the incidence rate of DGAC is increasing. Unlike IGC, DGAC
is more commonly observed in younger patients, females, and the Hispanic populations. DGAC is aggressive
and tends to be detected at later stages, resulting in poor prognosis and limited treatment options. DGAC is
resistant to systemic therapy, and the progress toward targeted therapy for DGAC treatment is relatively slower.
Additionally, biomarker-guided therapeutic options are limited. Therefore, the development of a new therapy is
crucial. The proposed study aims to unravel the mechanisms of DGAC tumorigenesis and apply that knowledge
to laying a foundation for DGAC therapy development. To address this, we established a model system that
recapitulates human DGAC tumorigenesis using genetically engineered gastric organoids and transplantation
approaches. Single-cell transcriptomics helped us delineate the cell dynamics, cells of origin, and cell plasticity
of DGAC. Our findings led us to identify potential drugs that target the root cells driving the neoplastic cell lineage
of DGAC. Based on the preliminary results, we hypothesize that drugs identified by single-cell transcriptomics
inhibit neoplastic cell lineages and suppress E-cadherin-negative DGAC tumorigenesis, which will be tested by
pursuing the following aim: To determine the impact of drug candidates on DGAC stemness, tumorigenesis, and
first-line treatment. Completing the proposed study will lay a novel foundation for DGAC therapy development
by determining whether targeting specific cell clusters inhibits E-cadherin-negative DGAC tumorigenesis.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) The proposed research is related to public health because determining the specific impact of drug candidates on E-cadherin-negative diffuse-type gastric cancer is expected to give rise to new types of biomarker-guided targeted therapy. Thus, this study is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.